Training in Environmental Toxicology

Funds are requested to support the Rochester Toxicology Training Program. The overall objective
of this program is to provide pre- and postdoctoral training for the next generation of talented,
independent toxicologists, who will conduct novel research, and actively transform these finding
into new information that will be used by scientists, public health and medical professionals,
governmental and other agencies, and the public to improve overall human health and well-being.
This program is distinguished by the success of prior trainees, remarkable collegiality and
extensive collaborations among faculty and trainees, a broad base of research support, and
strong leadership and institutional commitment. The program is dedicated to meeting diverse
needs for trainees from many backgrounds, and supporting trainees who seek careers in
academia, government and industry. The program’s framework is based on the belief that training
requires: (1) multidisciplinary and interdisciplinary approaches; (2) a close relationship between
trainee and mentoring team; (3) a culture that supports career development, trainee autonomy,
and diversity. The program takes advantage of the range of specialties and resources available
at a major academic medical center by reaching beyond the immediate confines of a single
department. While housed within the Department of Environmental Medicine, the 33 faculty
mentors come from 12 different basic science and clinical departments within the School of
Medicine and Dentistry at the University of Rochester. Faculty research spans the entire spectrum
of toxicology, from molecular mechanisms and cellular processes to whole animals and human
populations. There are 5 major focus areas (neurotoxicology, cardiovascular/pulmonary
toxicology, developmental/reproductive toxicology, immunotoxicology, musculoskeletal
toxicology), which cut across four contemporary themes: Molecular Modifiers of Toxicity,
Developmental Basis of Disease, Epigenetic Regulatory Systems, and Environmental Effects on
Stem Cells. During the current cycle of this training grant, new mentoring programs for trainees
and faculty have been developed, refinements to the didactic curriculum were adopted, and new
strategies to recruit and retain trainees from diverse backgrounds were implemented, including a
peer mentoring program. The program is also tightly integrated with other graduate and
postdoctoral programs and research support centers at Rochester. Thus, all trainees have access
to new institution-wide programs in career development, grant writing, critical thinking and more.

Public health relevance
Project Narrative The Rochester Toxicology Training Program provides support for graduate students and postdoctoral fellows interested in mechanistic toxicology research. This program trains future scientists who will help find ways to reduce the negative impact of chemicals and other environmental factors on human health, and discover novel ways to prevent and treat disease.